Adapting CAPABLE as CAPABLE-Family for the Caregiver Care-Recipient Dyad with Alzheimer's Disease and Related Dementias (ADRD) and Disability

Project Summary
Co-occurring physical and cognitive impairments are an important public health concern in older adults with
Alzheimer's Disease and Related Dementias (ADRD) leading to: decreased functional independence and
increased mortality. Caregiving for persons with co-occurring ADRD and physical disability is a direct risk factor
for nursing home placement for care recipients, and a source of chronic physiologic stress for caregivers resulting
in poor health, lost income, physical burden, psychological distress, social isolation and for those most
distressed, increased risk of mortality. Thus, it is important to maintain and improve the cognitive and functional
ability of older adults with ADRD and their caregivers. The majority of studies for physical interventions in older
adults with cognitive impairment focus on: (1) ADRD in later stages, (2) nursing home and long-term care facility
residents instead of home-based settings, and (3) few outcomes directly measured physical function (ADLs,
IADLs) with geriatric standards of care. The scientific gap is a physical intervention in older adults with cognitive
impairment which focuses on: (1) ADRD in earlier stages, (2) home-based settings, and (3) outcomes directly
measuring function with Katz ADLs and Lawton's IADLs. The CAPABLE program is currently implemented in
more than 30 sites across 16 states and uses the expertise of a Registered Nurse (RN), Occupational Therapist
(OT), and Handyworker (HW) to address the home environment and strengths of older adults with disability to
improve function, however excludes persons with ADRD. The purpose of this study is to address the needs
of older adults with co-occurring ADRD and physical disability and their caregivers with a human centered
design (HCD) program, CAPABLE-Family, using the Verbrugge and Jett Disablement Process Model as the
theoretical framework. The long term-goal is to offer CAPABLE-Family at CAPABLE sites across the nation,
providing benefits to a broader range of older adults. The specific aims are: SA1: To adapt the CAPABLE
program to focus on meeting the needs of older adults with co-occurring ADRD and physical disabilities and their
caregivers (CAPABLE-Family), and SA2: To evaluate the acceptability, feasibility, and preliminary effect size of
CAPABLE-Family in older. In SA1, the dissertation study, the applicant seeks to identify caregiver and care
recipient needs, such as: disability, environmental challenges, pain, depression, polypharmacy, provider
communication needs, and caregiver burden. This study aligns with the NIA's mission to include research on
chronic disabling, and degenerative diseases of aging, with a particular focus on AD; on multiple morbidities, on
individual behavioral changes with aging, and on caregiving. The 1-year protocol development includes:
contextual qualitative research, synthesis/ideation, and prototype testing from HCD with n=10 dyads, 10 RNs,
and 10 OTs. Phases 4/5 provide clinical trials research experience directed by the Primary Mentor. This research
contributes to the development of a goal-directed human-centered behavioral intervention for older adults.

Public health relevance
Project Narrative One in ten US adults age 65 and older has Alzheimer's disease, with some living as long as 20 years with co- occurring disability and dependence leading to an estimated $290 billion in health care, long term care, and hospice care. The purpose of this proposed study is to address the needs of older adults with co-occurring Alzheimer's Disease and Related Dementias (ADRD) and physical disabilities and their caregivers with a human-centered design program, CAPABLE-Family, using the Verbrugge and Jett Disablement process as the theoretical framework. The proposed study is well aligned with the National Institute on Aging (NIA) Strategic Direction for Research on Aging's Goal C to develop effective interventions to maintain health, well-being and function or reduce the burden of age-related diseases, disorders, and disabilities, and directly addresses age- related diseases, ADRD, and disabilities in older adults to improve their physical function and maintain health.